The role of pleural mesothelium in lung injury, repair, and regeneration

PROJECT SUMMARY
The mechanisms involved in lung repair and regeneration are still poorly understood and currently no clinical
techniques are available to specifically induce lung repair. In young tissues, the lung is appreciated to repair and
regenerate in response to damage. However, lung diseases such as idiopathic pulmonary fibrosis, are largely
considered diseases of aging and subsequent disordered repair. Current treatment options available are limited,
and mainly provide an option to slow disease progression, but none offer the ability to repair existing damage.
Improved understanding of repair and regenerative mechanisms could drastically improve the treatment options
available for these terminal fibrotic conditions. Of the cells studied in repair and regeneration, mesothelial cells
are largely excluded, presenting a gap in the knowledge base. While pleural mesothelial cells (PMCs) are largely
quiescent in healthy conditions, our preliminary data shows recruitment and migration of PMCs in a mouse model
of transient fibrotic injury. Compelling data also exists for PMC recruitment and migration in a mouse model of
lung regeneration. Contradicting this, other work has suggested that PMCs serve a role to stimulate fibrotic
progression, leading to confusion surrounding the function of these cells. The lack of study and contradictory
evidence regarding PMC functions in lung injury, fibrosis and repair sets the stage for detailed study of this cell
population and the signaling and functional roles it may play in these contexts. Using a combination of careful
lineage-tracing experiments, we will investigate PMCs in the bleomycin injury model, as well as in the
pneumonectomy compensatory growth and regeneration model. We will subsequently collect these cells for
further genomic analysis to assess expression of genes consistent with injury progression or controlled repair.
Our initial investigations into the signaling of PMCs has capitalized on the various lung single-cell RNA
sequencing dataset that are publically available. In multiple human and mouse datasets, the cell clusters
identified as mesothelium represent the exclusive lung cell type that expresses the Wnt mediator R-spondin 1
(Rspo1). Our preliminary data confirms PMC to be highly expressive of Rspo1. As Wnt signaling is a pathway
that has been well explored in contexts of injury and repair, this proposal will explore the ability of PMCs to
modulate Wnt signaling in the local environment but using organoid co-culture. The goal of these studies is to
provide context for the effect of these cells on specific cell types involved in lung injury and repair. Overall, the
studies may reveal a unique and unexplored potential to target pleural mesothelial cells and explore their
expanded role in lung function/dysfunction.

Public health relevance
PROJECT NARRATIVE Pleural mesothelial cells are often not included in the discussion of cells involved in lung injury and repair, largely because their role has yet to be thoroughly investigated. Intriguingly, these cells appear to be activated in both conditions. This project will study the involvement of pleural mesothelial cells in injury, repair, and regeneration and will investigate their direct impact on specific cell types in the lung to determine their contribution as pathogenic or reparative.